Administrative Core (Core A)

SUMMARY: ADMINISTRATIVE CORE (CORE A)
The Administrative Core, led by Dr. Frederick Lang (Director) and Dr. Juan Fueyo (Co-Director), provides
critical centralized administrative support to ensure the success of the entire SPORE. The specific objectives
of the Administrative Core are to:
• Oversee and administer all SPORE activities.
• Oversee all SPORE Projects and Core activities.
• Oversee the Developmental Research and Career Enhancement Programs.
• Promote integration and communication between the SPORE, the Brain Cancer Program, and the Cancer
Center Support Grant.
• Ensure compliance with institutional, governmental, and NCI regulations.
• Communicate and consult with the NCI program officer and other staff to ensure timely preparation and
submission of reports, publications, and important events that affect management of the SPORE.
• Oversee and administer all fiscal and budgetary activities of the SPORE.
• Manage and provide quality assurance, including data quality control, in cooperation with the Biostatistics
and Bioinformatics Core.
• Coordinate meetings of the Executive Committee, Internal and External Advisory Boards, monthly
investigator meetings, lectures, and symposia.
• Ensure compliance with and improvement of policies for recruitment of women and minorities.
• Coordinate with other Brain Cancer SPORE programs and investigators, as well as other organ site SPORE
programs, to promote research communication in meetings, distribution of materials, electronic
communications, and evaluation of progress reports.

Public health relevance
NARRATIVE: ADMINISTRATIVE CORE (CORE A) The Administrative Core provides the support and infrastructure for research, financial oversight, and regulatory monitoring. It achieves its goals by promoting clear and open communications among all SPORE investigators, Core leaders, Career Enhancement Program and Developmental Research Program awardees, External and Internal Advisory Board members, and patient advocates. Ultimately, it seeks to optimize the successful outcome of the translational research of this SPORE in order to improve the lives of patients with brain cancer.